A Synergistic Multistrain Live Biotherapeutic Product for the Prevention and Treatment of Necrotizing Enterocolitis

ABSTRACT
Necrotizing Enterocolitis (NEC) is an inflammatory disease of the intestines that primarily afflicts
preterm infants. In severe cases, intestinal tissue necrosis can lead to perforation, sepsis, and death.
NEC is estimated to develop in 7% of very low birth weight infants and carries an associated mortality
rate of 30-50%, making it one of the leading causes of death in preterm infants. To prevent colonization
and infection by opportunistic bacterial pathogens, preterm infants are commonly administered
antibiotics. While antibiotics remain effective for reducing NEC-associated infections and improving
outcomes, their broad-spectrum effects can disrupt intestinal colonization by protective bacterial species,
leave the intestinal tract open to reinfection, and drive antibiotic resistance in opportunistic pathogens.
An updated approach to NEC management that leverages protective bacteria to strengthen the
developing gut microbiota after antibiotic treatment is well overdue. At Siolta Therapeutics, we are
developing STMC-106, a multistrain Live Biotherapeutic Product (LBP) to prevent and treat NEC.
Unlike probiotic products, we will develop STMC-106 under an IND to meet the safety, efficacy, and
quality standards required for approval as a biologic product by the FDA. We hypothesize that treatment
with STMC-106, a rationally designed LBP containing multiple synergistic bacterial strains as active
ingredients, will reduce both opportunistic pathogen burden and intestinal inflammation to improve clinical
outcomes in NEC. To test this hypothesis, in Specific Aim 1 we will identify combinations of therapeutic
candidate bacteria for inclusion in STMC-106 that act synergistically to enhance NEC therapeutic
potential in vitro. Candidate consortia that display growth of all active partner strains on human breastmilk
through efficient metabolic cross-feeding will be screened to identify two top-performing consortia that
inhibit inflammatory signaling and enhance intestinal epithelial barrier function in vitro. In our Specific
Aim 2, we will evaluate the in vivo efficacy of two top-performing STMC-106 formulations in a neonatal
piglet model of NEC. We will test the efficacy of these two rationally designed bacterial consortia in both
a prevention and treatment model design. Efficacy will be evaluated based on the ability of the candidate
interventions to reduce intestinal inflammation and tissue necrosis and the burden of opportunistic
pathogens in the gut lumen. Our long-term objective is the clinical development and regulatory approval
of STMC-106, an LBP designed for preventing and treating NEC in high-risk preterm infants. Successful
development of this LBP could save thousands of preterm infants from this deadly illness each year.

Public health relevance
NARRATIVE Necrotizing enterocolitis is an often-deadly inflammatory disease of the intestinal tract that primarily afflicts preterm infants. In high-risk infants, antibiotics are commonly used prophylactically to reduce intestinal invasion by opportunistic bacterial pathogens that contribute to necrotizing enterocolitis, however use of antibiotics alone can disrupt gut colonization by protective bacterial species and leave the intestinal tract open to reinfection. To this end Siolta Therapeutics is developing a live microbial therapeutic, STMC-106, to colonize the high-risk preterm infant gut with a synergistic combination of protective Lactobacillus and Bifidobacterium strains and reduce morbidity and mortality from necrotizing enterocolitis.